Genetic and metabolic regulation of macrophage activation at steady state

Project Summary
Inflammation is essential for tissue repair and removal of harmful pathogens and molecules , but if activated
inappropriately, the innate immune system triggers autoinflammatory conditions. Macrophages play a key role
in inflammation and have tremendous impact on human health, both positive and negative, yet many questions
about these cells remain unanswered. They are heterogeneous and adopt a spectrum of activation states, both
as distinct tissue-resident macrophages and in circulation as monocytes. The drivers of these activation states
remain elusive. Metabolism plays a role, with macrophages undergoing metabolic changes during pro-
inflammatory activation, including switching from oxidative phosphorylation to glycolysis. However, whether
metabolism or other intracellular processes alone can dictate activation states remains unclear and is critical to
understanding a host of human diseases associated with inappropriate inflammation. The current proposed
research program addresses this question and significantly expands our previous work by analyzing these
processes in different organ systems (including the liver and the intestine).
We are leveraging the unique advantages zebrafish provide for exquisite genetic manipulations, high throughput
screening, and in vivo imaging to dissect the complex relationship between intracellular processes and
macrophage activation. The discovery of an inactivating mutation in a NOD-like receptor, nlrc3l, that causes
inappropriate macrophage activation and loss of microglia led us to create a new genetic screen in zebrafish that
yielded several novel macrophage mutations that we will investigate. These new mutations cause inappropriate
macrophage activation, disrupt microglia development or both. We are investigating whether nlrc3l and
associated genes as well as new genes we identify from the screen regulate macrophage activation by altering
metabolic and other intracellular processes. We are taking an integrated approach at multiple levels—using
differential transcriptomics, proteomics, and metabolomics, high power in vivo single cellular and whole-body
imaging, CRISPR based genetic engineering, protein-protein interactions, and cross-species
experimentations—to address these questions. Furthermore, our previous results raise critical new questions
regarding how activation states are regulated to ensure normal tissue macrophage development, and whether
common mechanisms exist to control macrophage activation across multiple organs. Our research program will
expand to address these key areas in vivo using a diverse set of tissue macrophages (microglia, intestinal
macrophages, and Kupffer cells). These studies aim to provide necessary insights into macrophage
differentiation, plasticity, and potential in a disease-relevant context, and address how seemingly disparate
functions (development and activation regulation) are encoded in the molecular program governing
macrophages. In summary, deciphering the molecular networks regulating immune activation is critical for
addressing health challenges associated with inappropriate inflammation, including diabetes, obesity, cancer,
and autoimmune diseases. Our research will lead to new knowledge and technologies needed to harness the
properties of macrophages for disease prevention and treatment.

Public health relevance
Project Narrative Understanding the molecular rules and network logic of macrophage activation has implications for the design of natural and synthetic macrophage-targeted technologies for controlling inflammatory processes. This new knowledge will lead to technological developments needed to harness the properties of macrophages for biological and engineering applications. The impact of these studies is far-reaching for addressing major public health issues associated with activated macrophages, chronic inflammation, and metabolic deficiencies, such as diabetes, obesity, and cancer.